Regulation of Adenylyl Cyclase Signaling Pathways

Summary
Adenylyl cyclase (AC) and its product, cyclic AMP, regulate functional outcomes in every mammalian tissue
and organ system, controlling processes such as learning and memory, motor coordination, cardiac
contractility, drug dependency and withdrawal, renal function, pain, stress, immune responses, and anxiety
behavior, to name just a few. Importantly, G protein coupled receptors that transmit signals via stimulation
(Gαs) or inhibition (Gαi) of AC are major clinical drug targets (e.g. beta-blockers for heart disease, opioids for
pain, or beta-agonists for asthma). Funded largely by NIGMS, my research career over the last 27 years has
focused on how the catalytic activity of AC enzymes are regulated by G proteins and other regulatory
molecules. Additionally, we are interested in how AC/cAMP signaling specificity can occur in a cellular
environment. We have identified multiple macromolecular complexes assembled by A-kinase anchoring
proteins that respond to low levels of local cAMP production upon anchoring of AC to the system, driving
physiological responses, or when altered, have pathophysiological consequences. However, many
fundamental questions remain about the mechanisms of AC regulation within these signalosomes, the
regulation of ACs by covalent modifications, and the potential for regulation of cellular events from intracellular
sites. To address these key questions, we have performed proximity dependent identification of near neighbors
(BioID) to build a comprehensive AC interaction network in cardiomyocytes and characterized new tools for
selectively probing the properties of AC9. These will be applied to broad projects that examine the scaffolding
of AC activity that ultimately control cardiac pacemaking and conduction. Popdc proteins act as one novel
scaffold for AC enzymes that promote AC activity within the complex to drive cAMP-dependent regulation of
TREK channels. The unique mechanism of AC regulation by Popdc and the localization of this complex will be
further explored in two related projects. Additionally, we will examine the mechanism of AC regulation by a
novel modifying enzyme, identified by BioID. Although these modes of regulating cAMP signaling will be
examined in the context of cardiomyocytes and cardiac function, many of the mechanisms are universal in
nature and have implications for many biological systems.

Public health relevance
Project Narrative Heart disease is the leading cause of death in the US (even in 2020), while the Center for Disease Control estimates that 6.1 million suffer from abnormal heart rhythms. Adenylyl cyclase produces the small molecule cyclic AMP that is a crucial regulator of cardiac function, including heart rate, in addition to many additional physiological processes. Our studies provide a better understanding of the mechanisms that regulate the local production of cyclic AMP and ultimately heart rate and will uncover new strategies for therapeutic interventions.